ANTIBODIES TO RECEPTORS--DETECTION IN DISEASE STATES AND USE AS PROBES

Autoantibodies to the insulin receptor occur in patients with insulin resistance as well as patients with hypoglycemia. Both in vitro and in vivo studies on the effects of anti-receptor antibodies to mimic or antagonize insulin action have been studied. While all of these anti-receptor antibodies can mimic insulin action, some of the antisera fail to stimulate the receptor-associated kinase activity. Anti-receptor antibodies can also mimic the effect of insulin to down-regulate receptors by accelerating receptor degradation. This effect of anti-receptor antibodies may play an important role in the desensitization of the target cell to the effects of insulin and to the insulinomimetic effects of anti-receptor antibody. Anti-insulin antibodies have been used as a probe for the interaction between insulin and its receptor. Polyclonal anti-insulin antibodies can immunoprecipitate the cross-linked I125-insulin-receptor complex. Sixteen monoclonal antibodies failed to immunoprecipitate receptor-bound I125-insulin. One monoclonal antibody immunoprecipitated the cross-linked I125-insulin-receptor complex, albeit poorly. These data suggest that the majority of the epitopes on the insulin molecule become sterically unavailable for antibody binding.